Extreme cell growth in support of stem cell proliferation and niche exit

Introduction: The nematode C. elegans has the ability to reversibly halt its development in
response to adverse environmental conditions that make reproduction unfavorable. Two of the
most well known diapause states are “dauer diapause,” a response to early life stressful
conditions, and “adult reproductive diapause” (ARD), resulting from experiencing stressful
conditions later in development. While there has been previous work on reproductive system
development in dauer and ARD, less is known about its recovery. We propose a project in
which the genetic mechanisms of recovery from each state are elucidated, culminating in a
comparison between genetic recovery from two different stress-states.
Aim 1: Characterize morphologic and gene regulatory changes during gonad recovery
Aim 1A) We will use live imaging to illuminate common defects in recovery from both dauer and
ARD; this will provide clues to the genetic pathways affected by, and necessary for, recovery.
Aim 1B) We will utilize RNAseq technology to determine differentially regulated genes in the
recovery from ARD; this will help elucidate genes implicated in ARD developmental recovery.
Aim 2: Identify genetic regulators of reproductive recovery from dauer and ARD
Aim 2A) We will perform a mutagen screen to discover genes that seem to serve specifically in
recovery from dauer and/or ARD, and are not implicated in continuous reproductive
development in non-stressful conditions (i.e. those that have post-diapause defects in
reproductive development but the same defects are not seen in a continuously fed population.)
Aim 2B) We will utilize a candidate approach to identifying genes important to dauer and/or ARD
recovery through virtually screening existing transcriptomics data, enriching for differentially
regulated genes known to function in the development of the reproductive system.
Aim 3: Understand the role of chromatin regulation in diapause and reversal
We will examine the role of broad transcriptional regulation through live imaging and assaying
chromatin compaction in the germline.
Training Plan: The proposed training plan will not only allow me to gain the technical skills
necessary to answer these interesting questions, but will also provide me with many
opportunities to improve upon my weaknesses as a scientist, such as opportunities for publicly
presenting my research. Additionally, the proposed training plan will give me the necessary
coursework to pivot towards a more Systems Biology oriented career in the future.

Public health relevance
If conditions are not suitable, some animals have the ability to pause growth and development, until conditions improve. We seek to understand how the genetic model organism C. elegans recovers fertility after developmental cessation induced by environmental stress. We will compare two arrest stages–one early in development and one late–to ask what features they have in common and in which ways they differ.